Optimizing the synthesis of[18F]FTMP for commercial distribution

Abstract
The development of genetic medicines such as gene and cell therapies like Chimeric Antigen Receptor (CAR)
T cells has necessitated new technologies that can monitor the biodistribution of these therapies in human
patients. Imaging is particularly well suited to provide such quantitative measurements of a genetic medicine
over time. Vellum Biosciences is a platform imaging company geared to fill this void in technology, providing
repeatable, robust, sensitive measures of a genetic medicine in situ with clear applications in new drug
development, clinical research, and eventually clinical practice. Vellum’s technology is based on positron
emission tomography (PET) radiotracer derivatives of the synthetic antibiotic trimethoprim (TMP) and its protein
target dihydrofolate reductase (DHFR). When DHFR is expressed in a genetically delivered medicine (e.g.
mRNA, lentiviral or adenoviral vectors), TMP radiotracers can be used to measure the expression of the protein
products in any tissue within the body. This strategy has been used to monitor the trafficking of CAR T cells
targeting several solid tumors in animals. In this STTR phase 1, we propose the development of a commercially
viable radiosynthetic route for broad, widespread distribution of TMP radiotracers. In AIM1, we will develop a
two-step radiosynthetic process which shall decrease the need for HPLC purification and co-develop a single
vessel synthesis which will be applicable to many commercial radiosynthesis modules. In AIM2, we focus on a
cartridge-based, solid-phase workup of the radiochemical products. Taken together these short-term goals
provide both the feasibility and tractability for commercial radiopharmacy production of TMP radiotracers. More
broadly, imaging is expected to be particularly important in the coming decades to validate and prioritize new
genetic medicine therapies. We have already formed relationships with global pharmaceutical companies to use
these technologies and envision that these approaches are critical to the advancement of next-generation
medicines for the continued improvement of human health.

Public health relevance
Narrative This phase 1 STTR proposal outlines the development of a commercially viable radiosynthesis for fluorine-18 trimethoprim, [18F]FTMP, a positron emission tomography (PET) imaging agent that is applicable to imaging gene and cell therapies in human patients that have been engineered with a PET reporter gene. The ability to detect and quantitatively measure such therapies in human patients would pave the way to new and better genetic medicines. Our approach would decrease the need for biopsies and impact in specific areas that are in need of imaging biomarkers, including the use of chimeric antigen receptor (CAR) T cells for solid tumors.